Early life exercise effects on tendon maturation and resistance to late life tendinopathies

Project Summary
Tendons serve multiple critical roles in locomotion, and functionality can be compromised by the effects of
aging, disuse, and tendinopathy. For the aging population, the combination of these factors greatly reduces
mobility and contributes to the likelihood of falling. Many structural changes that occur with age and/or training
in tendon have been shown to impact tendon mechanics, including changes in cross-sectional area (CSA),
straightening of collagen fibrils, and increase in advanced glycation end-products (AGEs). Exercise can
mitigate some of these age-related declines, but previous studies have demonstrated that the ‘core’ of tendons
is fully formed by skeletal maturity and thus the capacity of tendon to respond to load is limited post-maturation
[16,17]. Despite this documented phenomenon, the response of tendon to loading in early life tendon is largely
unknown, nor its consequences for later life tendon performance. This proposed research aims to address two
key and related gaps in the understanding of ontogenetic interactions with tendon loading—how tendon
loading in early life impacts later life tendon mechanics, and how early life tendon adaptation to load differs (if
at all) from mature tendon. We will test the potential for early life exercise to protect against late-life
tendinopathy and identify structural mechanisms contributing to differing tendon functional morphology
between juvenile-loaded tendons and adult-loaded tendons using a 10-week exercise treatment in a mouse
model. Tendons will be harvested and undergo mechanical testing both immediately following the training as
well as 12 months later to test the ability of early life exercise to enhance late life tendon quality. The formation
of the tendon core and its response to loading in early life will be assayed using histology and stable isotopes,
thus capturing the regional response of tendon to loading at these life stages.

Public health relevance
Project Narrative The percentage of the US population over the age of 60 is growing steadily, and issues affecting quality of life and mobility of the elderly are of significant concern. Tendinopathy in later stage aging may be impacted by adolescent exercise, but the relationship between these phenomena is not well understood. This project aims to test if early life exercise relates to improved tendon performance in late life, and seeks to understand the contributing mechanisms.